SCALE: Strategies for Implementing GlobalConsent to Prevent Sexual Violence in University Men

PROJECT SUMMARY ABSTRACT
Significance. Globally and in Asia/Pacific, women 15–24 years (y) are at heightened risk of exposure to sexual
violence, including at university. The burden of sexual violence is higher for women than men, and men most
often are the perpetrators. Sexual violence in adolescence is a risk factor for gender-differentiated mental,
physical, and behavioral health conditions in adulthood and is costly for victims and societies. Evidence-based
prevention programs tailored to university men in low- and middle-income countries (LMICs) are rare. Our team
developed GlobalConsent, a theory-based, six-module educational entertainment program adapted from an
efficacious program tested with university men in the US. In a large attention-controlled trial at two universities
in North Vietnam, GlobalConsent reduced men’s sexually violent behavior (OR=0.71, 95%CI 0.50-1.00) and
increased pro-social bystander behavior (OR=1.51, 1.00-2.28) 9 months post-treatment. Evidence on real-world
implementation is needed. Aims. We will compare the 1) implementation, 2) implementation drivers and
outcomes, 3) implementation effectiveness, and 4) cost-effectiveness of delivering GlobalConsent using one of
two bundled implementation strategies. Approach. We will randomize six medical universities in North, Central,
and South Vietnam to deliver GlobalConsent to eligible first-year male students using lower-intensity (standard)
or higher-intensity implementation strategies salient to university stakeholders in Vietnam. Higher-intensity
strategies will include those in the lower-intensity group plus more 1) implementation and post-implementation
educational outreach with university leaders, 2) pre-implementation leadership training and external
implementation support to university facilitators, and 3) pre-implementation educational outreach, implementa-
tion follow-up, and incentives to foster student adherence and demand to complete GlobalConsent. Our mixed-
methods comparative interrupted time-series design includes 1) qualitative research with university leaders and
implementation teams to compare implementation and implementation settings; 2) repeated surveys with
leaders, implementation teams, faculty, and male students to compare implementation drivers and outcomes, 3)
10 quarterly surveys with male students to compare primary behavioral and secondary knowledge, attitudinal,
and affective outcomes, and 4) cost data to compare the cost effectiveness of the two implementation strategies
bundles on incidents of sexual violence averted. Innovation/Impact. This project is the first to assess two
bundled implementation strategies to deliver an efficacious web-based sexual-violence-prevention program
tailored to university men in Vietnam. Including university partners across Vietnam enables us to test these
strategies in diverse regions and to synergize this effort with in an on-going violence-prevention training initiative
(D43TW012188). Our state-of-the-art approach will produce rigorous evidence that can inform dialogue with
officials about how to deliver GlobalConsent nationally. This project is poised to reduce gender-based health
inequities linked to early sexual violence and to strengthen national capacity to bring GlobalConsent to scale.

Public health relevance
PROJECT NARRATIVE This project will be the first to compare lower-intensity (standard) and higher-intensity implementation strategies to deliver GlobalConsent—an efficacious web-based sexual-violence prevention program—to men attending six universities across Vietnam. Following a rigorous, mixed-methods, comparative interrupted-time-series design, we will collect novel data to compare implementation fidelity, drivers and outcomes, effectiveness, and cost- effectiveness across implementation strategies groups. Our partnership includes universities also engaged in a violence-prevention training grant (D43TW012188), offering an unparalleled opportunity for capacity strengthening and evidence generation to guide national leaders on best strategies for launching GlobalConsent at scale, to address a gendered risk factor in adolescence, and thereby, improve an array of health outcomes into adulthood.